Generating functional diversity from molecular homogeneity at glutamatergic synapses

PROJECT SUMMARY
Synapses are fundamental units of communication in the nervous system, where immense
diversity in structure and function serve to tune and calibrate information transfer. Defects in the
ability of synapses to properly diversify contribute to the etiology of a variety of
neurodevelopmental, psychiatric, and neurodegenerative diseases. One means of generating
diversity in synaptic function is through molecular heterogeneity, where combinations of distinct
genes are expressed at individual synapses to enable specific functional properties. However, it
has become increasingly clear, though difficult to resolve, that remarkable synaptic diversity can
be achieved from a limited set of molecular machinery. In principle, the Drosophila neuromuscular
junction (NMJ) is a uniquely powerful model to address how synaptic diversity is generated given
the sophisticated genetic, electrophysiological, and imaging approaches. In this system, two
distinct motor neurons converge to co-innervate individual muscle targets, where transmission
from a strong and weak input together drive muscle contraction in the motor circuit. However, an
inability to selectively isolate transmission from either input has been a major limitation towards
understanding synaptic diversity in this system. Here, we propose to use expression of a unique
Botulinum NeuroToxin (BoNT) to selectively silence transmission at strong or weak synaptic
inputs. Preliminary data suggests that while each neuron is largely composed of the same
molecular machinery at active zones, one core component, previously thought to function
universally at all active zones, actually subserves dramatically different roles at strong vs weak
synapses. We will use BoNT silencing, super resolution imaging, and the latest calcium reporters
targeted to release sites to illuminate differences in active zone nanostructure and function
between strong and weak synapses. We will also leverage new innovations in CRISPR
mutagenesis to dissect the specialized functions of eight core active zone components at strong
vs weak synapses. Finally, we will interrogate how these core active zone components are
uniquely targeted for modulation and remodeling at strong vs weak synapses in the context of
homeostatic synaptic plasticity. Together, these approaches will unlock fundamental insights into
how glutamatergic synaptic diversity is established and adaptively modified through plasticity.
Ultimately, this understanding will illuminate key mechanisms through which heterogeneous
functional properties at glutamatergic release sites are enabled by a limited molecular toolkit.

Public health relevance
PROJECT NARRATIVE Synapses are the primary substrates driving information transfer throughout our nervous system. Defects in synaptic communication are associated with a vast number of neurological, neurodegenerative, and neuropsychiatric diseases including epilepsy, autism, schizophrenia, ALS, and Alzheimer’s Disease. While their importance is undeniable, the mechanisms that establish and modulate the diversity of synaptic strength remain enigmatic. This proposal seeks to reveal fundamental insights into what determines and adaptively modifies the diversity of presynaptic function at glutamatergic synapses in development and plasticity. Ultimately, this knowledge is necessary to understand the etiology of neural diseases resulting from synaptic dysfunction and develop effective therapeutic strategies.